Training Program in Psychiatric Genetics and Translational Research

DESCRIPTION (provided by applicant): This competitive renewal application (revised) is for continuation of the joint training program in psychiatric epidemiology and biostatistics at the Harvard School of Public Health (HSPH). The principal objectives of the training grant are to educate promising pre- and post-doctoral trainees as epidemiological and biostatistical scientists in psychiatric research, with two focus areas: psychiatric genetics and analytical methods for translational research. We aim to train psychiatrists and other mental health researchers in methods relevant to these two fields, and to train methodologists working in these areas with genuine engagement in psychiatric research and an understanding of psychiatric diagnosis, assessment, and outcomes. The Departments of Biostatistics and Epidemiology at HSPH have an accomplished faculty who has worked collaboratively in these two areas for many years. We also draw on the expertise of Harvard faculty from other world-renown institutions, including the Harvard Medical School, Massachusetts General Hospital, Brigham and Women's Hospital, and McLean Hospital. These collaborations offer a rich source of ongoing projects for student and postdoctoral training. We are requesting a total of nine trainees across the two departments, five pre-doctoral, two post-doctoral degree candidates (psychiatrists seeking masters or doctoral degrees) and two post-doctoral non-degree candidates. Training will be a combination of coursework, seminars, practica, and independent and collaborative research in mental health. High level training in the companion core disciplines of epidemiology and biostatistics is critical to leadership of mental health research in the coming decades.